Regulated and evolutionary responses to nutritional stress

SUMMARY
My lab has pioneered studies defining how cells initiate and maintain a quiescent state in the face of nutrient
deprivation and quantifying the role of copy number variation in rapid adaptive evolution. In this proposal, we
have outlined two central areas of research that extend this work. The first project is aimed at investigating
how protein expression programs and cellular biology is remodeled in quiescent cells. Cell quiescence
is the dominant state of all cells, but the most poorly understood. Our prior research has defined the genetic
requirements for quiescence and quantified genetic interactions with evolutionarily conserved signaling
pathways that are required for quiescence. In our proposed research we will study the dynamics of gene
expression remodeling in quiescent cells at the level of protein expression using metabolic labeling and mass
spectrometry. We will define the role of key signaling pathways by studying defects in gene expression
remodeling in strains mutant for TORC1, PKA, AMPK, and PHO85. To study remodeling of the cellular
environment in quiescence we will use genetically encoded multimeric nanoparticles (GEMs) and live cell
imaging to quantify changes in cellular crowding in quiescent cells. We will also study mutants in vacuole
biogenesis to test the role of this organelle in reorganizing the cellular environment in quiescence. We will
define genetic factors that contribute to drug tolerance in quiescent cells and leverage this information to test
approaches to increasing antifungal drug effectiveness in quiescent cells in the fungal pathogens Candida
albicans and Candida glabrata. Our second project is aimed at understanding the dynamics of copy
number variation in evolving populations and their functional consequences. Copy number variants
(CNVs) are a prevalent source of genetic variation in humans, in which they underlie both heritable diseases
and pathogenic somatic variation. CNVs underlie phenotypic variation in a range of organisms and often
confer resistance to therapeutic treatment in pathogenic microbes. Our studies have demonstrated that CNVs
are frequent drivers of rapid adaptive evolution during microbial experimental evolution in chemostat cultures.
We have developed a combined CNV reporter and lineage tracking system that enables accurate
quantification of CNV dynamics in efficient methods for multiplexed mutant analysis. Using a combination of
these approaches, we will study the dynamics of CNV-mediated adaptive evolution in fluctuating environments.
We will then test the fitness effects of CNVs in conditions in which they have been selected, in which we
expect them to confer a fitness benefit, and a diversity of additional conditions, in which we expect them to be
neutral or deleterious. By incorporating known features of CNVs, we will build a quantitative model of their
fitness costs and benefits. To investigate the functional effects of CNVs we will quantify their gene expression
consequences at the level of mRNA abundance and ribosome occupancy and test their effect on gene
expression heterogeneity using single cell RNA sequencing.

Public health relevance
NARRATIVE My lab has pioneered work defining the regulation of cell quiescence and elucidating the role of copy number variation in adaptive evolutions. We aim to extend these advances by studying i) remodeling of gene expression and cell biology in quiescent cells and ii) the dynamics and functional effects of copy number variation. These studies build on our prior work and will contribute to our understanding of cell quiescence and copy number variation in the context of human health and disease.